The trigger and homeostatic function of a novel immune-sebum circuit

PROJECT SUMMARY
Sebum provides vital functions to the skin including moisture retention and defense against foreign inva-
sion. Despite the well-defined immunologic function of sebum, immune system regulation of sebum’s role in
cutaneous homeostasis is unknown. A lipid-rich substance produced in sebaceous glands (SGs), sebum con-
tains fatty acids and induces antimicrobial peptide expression. Sebum secretion increases with puberty onset
and is thereafter regulated in part by androgenic hormones. Sebum hypersecretion predisposes to acne vulgaris,
whereas insufficiency could disrupt skin barrier function as seen in atopic dermatitis. As current therapeutics
targeting SGs can be harmful and often ineffective, there is a critical need for further research into additional
mediators of sebum secretion, without which clinical treatment of sebum dysregulation remains lacking.
We have found that absence of the keratinocyte derived cytokine thymic stromal lymphopoietin (TSLP)
receptor disrupts sebum secretion and that signaling occurs through T cells, supporting the existence of an
immune-sebum regulatory circuit. We propose to identify the activating signal that mediates this T cell response
and initiates immune-sebum regulation. Skin commensal bacterial communities promote tissue-specific immune
system development, including generation of tissue-resident, microbial-specific T cells. It is possible that the skin
microbiome is involved in regulating SG function through T cell activation. Indeed, preliminary results show that
germ-free (GF) mice secrete less sebum than controls. This leads to the overall hypothesis that skin microbiota
induces TSLP-mediated, microbial-specific T cell-dependent sebum secretion, promoting skin barrier function
and acting as an important homeostatic innate defense against skin infection. Aim 1 involves conventionalizing
GF mice with skin commensal bacteria from controls to determine the necessity of skin microbiota for appropriate
sebum secretion. Transgenic murine models will be used with bacteria engineered to express an ovalbumin
antigen to determine if regulation occurs through microbiota-specific T cells. In Aim 2, TSLP receptor knockout
mice will be used to determine if, at homeostasis, TSLP-mediated sebum secretion (1) promotes skin barrier
function by measuring transepidermal water loss, hydration and pH, and (2) prevents infection in a Staphylococ-
cus aureus epidermal infection model. This research will form a foundation to allow identification of novel thera-
peutic targets for common cutaneous conditions associated with sebum dysregulation.
In order to complete these experiments and further my development as a physician-scientist, a rigorous
training plan has been proposed focused on the refinement of my experimental design and implementation,
scientific communication, research collaboration, and mentorship skills. This training will take place at the Uni-
versity of Pennsylvania where I will continue to improve my integration of scientific research and patient care
with the guidance and programming offered by the Medical Scientist Training Program. This presents a highly
innovative and resource rich environment for me to develop as a future dermatologist-scientist.

Public health relevance
PROJECT NARRATIVE Sebum is an oily cutaneous substance that performs critical functions for the skin, including moisture retention, emollition, and innate defense against infection. Previously thought to be solely controlled by androgenic hormones, we have identified an immune-mediated regulatory circuit of sebum in homeostatic murine skin which is disrupted in germ-free mice. This proposal identifies a novel skin microbiota-immune-sebum circuit and presents an important alternative pathway to influence sebaceous secretion, allowing for identification of safer and more effective therapeutics for overwhelmingly common skin conditions such as acne vulgaris.